Systematic Analysis of Morphogenesis, Commensalism, and Virulence in a Leading Human Fungal Pathogen

SUMMARY/ABSTRACT
Fungal pathogens pose a devastating threat to human health, infecting billions of people worldwide and
causing more than 1.5 million deaths each year. Candida albicans is one of the most pervasive fungal pathogens,
killing almost 40% of people suffering from bloodstream infections. Treating these infections is extremely difficult,
as fungi are closely related to humans and there are very few drugs that kill the fungus without host toxicity. With
the emergence of drug resistance, the development of new therapeutic strategies is now crucial. To address
this important clinical need and identify new antifungal drug targets, it is critical to uncover mechanisms
that enable C. albicans to cause life-threatening human disease.
We are one of the first academic labs to obtain a powerful functional genomics resource that we are
uniquely positioned to expand to allow us to test the function of almost every gene in the C. albicans genome.
This resource includes a collection of conditional expression strains that covers ~40% of the genome where one
allele of a target gene is deleted in the diploid pathogen, and expression of the remaining wild-type allele is
governed by the tetracycline-repressible promoter. During the prior funding period we: developed a pipeline to
expand the resource to genome scale, optimized a functional genomics platform for massively parallel analysis
of fungal virulence traits using next generation sequencing with pooled assays to quantify the relative proportion
of each strain, which are uniquely marked with molecular barcodes; optimized high-resolution image analysis of
cellular morphology and structures; and developed assays for identifying genes important for commensalism,
virulence, and interaction with host immune cells. Our efficient high-throughput analyses established the power
of systematic genetic analysis to uncover new biological insights that could not have been predicted based on
current paradigms and enabled focused, hypothesis-driven dissection of key mechanisms governing host-
pathogen interactions. Our studies will provide the first global analysis of C. albicans morphogenesis,
commensalism, and virulence, and will reveal fundamental biological mechanisms that could not be
predicted without a systematic genetic approach.
Our studies will: 1) complete the collection of tetracycline-repressible conditional expression strains to
cover non-essential genes, since genes required for pathogen viability in vitro provide little insight into host
adaptation or virulence; 2) identify novel regulators of key virulence traits such as morphogenesis; and 3) identify
determinants of C. albicans host adaptation and virulence on a genome scale. Our comprehensive strain
resources and compendium of phenotypic profiles will be made available to the community, advancing the field
with a publicly accessible database and interpretive machine learning model to maximize insight. This work will
provide the most comprehensive functional genomics resource for any fungal pathogen and will reveal
genes governing host adaptation, revealing new strategies to cripple fungal pathogens.

Public health relevance
PROJECT NARRATIVE Candida albicans is the leading fungal pathogen of humans, responsible for ~100 million mucocutaneous infections and ~500,000 invasive infections every year; despite the devastating impact of these diseases, only a handful of drugs are available for treating invasive infections, with mortality reaching ~40%. This project will build and leverage the most comprehensive functional genomic resource for a fungal pathogen to provide a global view of genes that are required for this opportunistic pathogen to thrive in the host and cause disease. By developing high-quality comprehensive datasets and strain resources for the community using cutting-edge methods, this investment will transform the field, yielding unexpected biological insights and facilitating the development of much-needed antifungal drugs.